MHCRC FOR ORGANIC AFFECTIVE AND SCHIZOPHRENIC DISORDERS

The Mental Health Clinical Research Center at NYU has provided a new organizational structure in the medical school that has enabled investigators to work together to improve our understanding and treatment of three major psychiatric illnesses: organic mental syndrome, affective disorders and schizophrenia. Specifically, the Center has been organized in order to: (1) provide string and effective leadership in the development of collaborative studies involving clinical investigators and basic scientists, (2) develop control procedures to insure that the best possible research is carried out, (3) provide Core resources to investigators in the center in order to facilitate research design, diagnostic and behavioral assessment, statistical analysis and access to a computer facility, (4) provide Core laboratories to investigators in the Center so that specialized tests and procedures can be carried out in conjunction with clinical and basic science studies, (5) provide seed money in order to encourage quality pilot proposals, particularly by young investigators, (6) facilitate recruitment of normal volunteers, symptomatic volunteers and patient volunteers, (7) provide a setting in which both didactic and preceptor type training can be provided to students, postgraduates and other relevant groups, (8) provide an institutional framework for the training and development of young investigators, (9) establish a resource, in the designated areas of interest of the Center, for the school, the community and the broader scientific community and (10) carry out periodic rigorous external review and criticism in order to maintain the most effective leadership and quality of scientific research.